Transcriptional mechanisms of chronic inflammation in genetically diverse tissue macrophages

PROJECT SUMMARY/ABSTRACT
Metabolic dysfunction–associated steatotic liver disease (MASLD) is an inflammatory liver disease associated
with progressive fibrosis, cirrhosis, hepatocellular carcinoma, and death from cardiovascular disease. Despite
knowledge of MASLD risk loci identified in genome wide association studies (GWAS), it is not yet possible to
predict MASLD using DNA sequences alone, justifying an urgent requirement for additional research on genetic
mechanisms of MASLD. One cell type that is instrumental to sensing and responding to tissue changes during
MASLD are Kupffer cells, the predominant liver resident macrophage. Kupffer cells contribute to MASLD
progression by promoting local and systemic inflammation, immune cell infiltration, hepatocellular damage, and
fibrosis. Additional research on the function and recruitment of Kupffer cells is important for understanding
MASLD because blocking macrophage infiltration or globally ablating macrophages protects against severe
disease in experimental models. A major shortcoming in our understanding of MASLD and associated
inflammation is that most preclinical studies assessing Kupffer cell biology occur in a single genetic background.
This shortcoming is significant because disparate phenotypes exist in MASLD models between inbred mouse
strains, similar to the varied outcomes in the genetically diverse human population. Importantly, more than 90%
percent of trait linked genetic variants are found in noncoding regulatory regions that control gene expression in
cell type– and context–restricted manners. Therefore, studies defining roles for genetic variation in controlling
transcriptional regulatory mechanisms in Kupffer cells may unveil novel insights into inflammation and MASLD
relevant to human disease. In our recent publication, we predicted the identities of many transcription factors
and pathways linked to allele–specific regulation of Kupffer cell gene expression in response to acute
inflammation. However, we still do not understand with cell type resolution how genetic variation contributes to
MASLD. For this proposal, the central hypothesis is that genetic variation controls the environmental signals
sensed by Kupffer cells and that knowledge on regulatory mechanisms will identify new pathways relevant to
MASLD in human patients. In specific aim 1, we will define genetic mechanisms controlling Kupffer cell
transcription during experimental MASLD. In specific aim 2, we will assess the feasibility of gene editing for
defining strain-specific functions of in vivo liver macrophages using an innovative combination of CRISPR/Cas9
and bone marrow transplantation. These results will support feasibility for expanded functional studies assessing
roles for genetic variation in Kupffer cells during disease and be extendable to tissue macrophages from other
organs and disease contexts. This research may define novel pathways and mechanisms controlling
macrophage participation in MASLD pathogenesis, which may be required for the development of novel
therapeutics.

Public health relevance
PROJECT NARRATIVE Cellular responses to inflammation and disease are controlled by genetic variants and environmental signals. This proposal will resolve the effects of genetic and environmental interactions responsible for transcriptional regulation of genetically diverse tissue macrophages in an experimental model of metabolic dysfunction- associated steatotic liver disease. Results from these studies will define novel cellular and molecular mechanisms relevant to clinical diversity of humans with metabolic dysfunction-associated steatotic liver disease.